Studies on the SARS-CoV-2 Main Protease Dimerization Mechanism

ABSTRACT
The main protease enzyme (Mpro) of SARS-CoV-2 cleaves the viral polyprotein into functional units responsible
for virus replication and pathogenesis. Interestingly, Mpro functions only as a homodimer. However, the structure-
function relationship and conformational plasticity of the Mpro dimerization mechanism remains poorly
understood. To address these gaps in knowledge, I have developed quantitative luciferase-based reporter
assays for Mpro dimerization in living cells and in vitro. I propose first to use these assays to study the Mpro
dimerization mechanism through the construction and analysis of a panel structure-guided and evolution-
informed mutants, as well as through targeted deep-mutational scanning of dimerization interface residues.
Second, I will use my luciferase-based reporter assays to identify candidate dimerization inhibitors. Third, I
additionally propose to use my luciferase-based reporter assays to perform studies on the (likely allosteric)
mechanism of inhibitor-facilitated dimerization. Altogether, the proposed studies will yield new assays for
studying coronavirus protease biology, unique insights into the mechanisms of Mpro dimerization and its allosteric
modulation, and novel compounds that can be used as chemical probes of these molecular mechanisms.

Public health relevance
PROJECT NARRATIVE The main protease enzyme (Mpro) of SARS-CoV-2 is required for virus polyprotein cleavage, replication, and pathogenesis, and it is a validated drug target as evidenced by the efficacy of Paxlovid. Mpro functions as a homodimer, and studies here investigate the molecular mechanism of dimerization. A detailed understanding of this molecular mechanism will advance fundamental knowledge and provide starting points for the development of a new class of drugs that works differently from Paxlovid by blocking dimerization.